Tobacco Control Program

Tobacco Control Program: Summary
Scientific Goals
The mission of the HDFCCC Tobacco Control (TO) Program is to reduce the burden of cancer caused by
tobacco, locally, in the catchment area, and globally. This mission is advanced through robust Program themes
reaching from the molecular level of tobacco-induced disease, to the physical and medical health effects of
tobacco, to individual and community tobacco cessation efforts, and to policy and regulatory actions at state,
national, and global levels.
Theme 1: Biological determinants of tobacco-induced addiction and disease
Theme 2: Social and behavioral determinants and interventions for tobacco addiction
Theme 3: The tobacco industry as a disease vector and strategies to block it
TO Program: Key Metrics
Membership (9 departments, 4 schools) 28
Full 14
Associate 14
Cancer-relevant Funding (direct costs as of
$9,353,958
05/31/2017)
NCI $2,506,751 27%
Peer-reviewed $4,804,645 51%
Non-peer-reviewed $2,042,562 22%
Cancer-relevant Publications (1/2012-7/2017) 492
Inter-programmatic 16 3%
Intra-Programmatic 127 26%
High-Impact 255 52%
Accruals to Clinical Trials (2016) 7350 20
Therapeutic 0 0
Other Interventional 75 4
Non-interventional 7275 16